Role of IGF-1 and insulin receptors beta-cell survival

PROJECT SUMMARY
The number of people with diabetes worldwide is predicted to increase from 415 million in 2015 to 642 million
in 2040. The health care costs of treating the disease account for 12% of the global health expenditure and
continue to be a huge economic burden (IDF World Atlas 2015). Type 1 diabetes mellitus (T1DM) constitutes
10-15% of the disease burden and is an autoimmune disease, thought to be triggered by genetic or
environmental factors in early childhood, which results in antibody-mediated destruction of insulin producing
pancreatic β-cells causing life-threatening hyperglycemia. In contrast, type 2 diabetes mellitus (T2DM)
develops later in life and results from insulin resistance in target tissues and inflammation coupled with an
inadequate compensation by the β-cells. The latter question has emerged to be important in this field that
requires attention. This application is focused on addressing the specific question of how beta cells are able to
compensate for the ambient insulin resistance by enhancing secretion and/or increased cell numbers in some
individuals but not others. We especially address this question in the context of growth factors and proteins in
their signalling pathways that are important for regulating β-cell proliferation, apoptosis and secretory function.
Our studies are driven by the work accomplished in the previous cycle where we identified m6A as an
important RNA modification with the ability to determine mammalian beta cell mass and secretory function.
During these studies we observed a link with mRNA modification and beta cell compensation in response to
insulin resistance. Our preliminary data identified a novel protein with the ability to regulate glucose sensing
and modulate beta cell proliferation and viability. We now seek to interrogate the direct relevance of this protein
in mammalian beta cells to identify the signatures that might provide important clues to processes that
contribute to beta cell compensation and maintenance of normoglycemia. In this proposal we will: 1)
Characterize and phenotype a novel mouse model with a beta-cell specific knockout of the chromatin-
regulating protein in the context of glucose homeostasis and islet function; 2) determine the mechanism of
action of the protein in the context of insulin signaling and Rho-kinase pathways in regulating human β-cell
mass, viability and secretory function; and 3) explore the relevance of the m6A RNA demethylase by
phenotyping a beta-cell specific knockout of Alkbh5 to study its impact on beta cell secretory function and
growth. All studies will include key experiments in human islets and beta cells to establish translational
relevance.

Public health relevance
PROJECT NARRATIVE The mechanisms and pathways that operate during the compensatory beta cell response(s) to ambient insulin resistance that delay the onset and/or progression to overt diabetes are not fully understood. We will interrogate the pathways linked to methylation marks on ribonucleic acids that contribute to regulation of key chromatin proteins in determining enhanced human beta cell secretion and mass. We seek to explore the role of proteins that regulate chromatin networks in islets/beta cells in the long-term goal of gaining insights into the pathophysiology during the compensatory process of this chronic disease.